Riboflavin Synthesis and Transport in Mycobacterium tuberculosis

PROJECT SUMMARY / ABSTRACT
Metabolic pathways that Mycobacterium tuberculosis (Mtb) requires for growth represent promising targets for
development of novel antibiotics to shorten tuberculosis (TB) treatment and combat multidrug resistant TB. Mtb
requires the de novo riboflavin synthesis metabolic pathway for growth in vitro, but whether Mtb requires
riboflavin synthesis during infection or can scavenge sufficient riboflavin from host tissues has not been directly
tested. Knowledge of the Mtb riboflavin synthesis and transport mechanisms and their importance during
infection will be critical to exploit these pathways for development of new TB drugs. The overall objective of this
proposal is to define the importance of riboflavin synthesis and transport to Mtb survival in the host. The central
hypothesis is that Mtb requires de novo riboflavin synthesis for replication and/or survival during all stages of
mammalian infection, despite the existence of dedicated riboflavin transporters, because it cannot acquire
sufficient riboflavin from host tissues. Preliminary data using a Mtb strain that conditionally expresses RibA2,
which catalyzes the first step of riboflavin synthesis, provide compelling support for this hypothesis, which will
be tested in three specific aims. Aim 1 will use the RibA2 conditional expression strain to determine the impact
of riboflavin starvation on Mtb physiology and drug susceptibility and develop a panel of Mtb strains with
hypomorphic expression of riboflavin synthesis enzymes to enable future drug discovery efforts. Aim 2 will
determine the extent to which Mtb requires riboflavin synthesis in macrophage and mouse infection models
using the RibA2 conditional expression strain. Aim 3 will use a synthetic lethal genetic screen to identify Mtb
riboflavin transporters. The approach uses innovative genetic strategies to identify mechanisms of riboflavin
transport and to identify synergy between riboflavin synthesis inhibition and existing anti-TB drugs. The
proposed research is significant because it is expected to establish riboflavin synthesis as a viable target for
development of new anti-TB drugs by demonstrating that riboflavin synthesis inhibition kills Mtb in mammalian
infection models and sensitizes Mtb to existing antibiotics. The proposal will also lay the foundation for high
throughput screens to identify small molecule riboflavin synthesis inhibitors with antibiotic activity.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because Mycobacterium tuberculosis sickens and kills more people worldwide than any other bacterial infectious agent. New drugs are needed to shorten tuberculosis treatment and combat multidrug resistant M. tuberculosis. The proposed research is relevant to the mission of the NIAID to support basic research to better understand and treat infectious diseases because it will generate fundamental knowledge on the extent to which M. tuberculosis relies on riboflavin synthesis during mammalian infection, which can be applied to develop new antibiotics targeting riboflavin synthesis to treat tuberculosis.